Impact of household air pollution (HAP) in-utero through early childhood on neurocognitive development from infancy to 8 years (HAPCOG Study)

ABSTRACT
Around the world, 93% of children under age 15 breathe toxic air every day that puts their health and
development at risk. Of 7 million deaths per year attributable to air pollution, over 60% are due to exposure to
household air pollution (HAP) from burning biomass fuels or kerosene for household energy needs. Such fuels
burn inefficiently, producing toxic pollutants like fine particulate matter (PM2.5) and black carbon (BC). Mothers
and children suffer the highest exposures, resulting in respiratory, cardiovascular, and neurologic injury. Risks
to children begin in-utero. Pregnant women inhale polluted air, with ill effects on their developing fetuses and
newborns, including growth restriction, preterm birth, and low birth weight. Mounting evidence suggests that
HAP can impair infant and child neurocognitive development. Particulate matter deposits in brain tissue
have been demonstrated; also, HAP is a medium of exposure to heavy metals. High exposures likely induce
oxidative stress and systemic inflammation. There is evidence of mediating factors: maternal stress level,
mother/child nutritional status, and home environment. We will explore the impact of HAP exposures on child
neurocognitive development, assessing the influence of known mediating factors. Our research capitalizes on
a unique opportunity flowing from a recent randomized controlled trial (RCT) in Nigeria. We randomized 324
pregnant women into groups based on fuel use: clean versus polluting. Polluting-fuel users showed: 1)
increased preterm delivery, miscarriage, and reduced gestational age at delivery, 2) biomarkers of placental
oxygen deprivation, 3) excessive placental vascularization, and 4) increased systemic inflammation. We further
found that polluting-fuel users reported more psychosocial stress and less energy during pregnancy. We have
continued to follow the RCT children (DISCOVERY COHORT), monitoring their HAP exposures. We propose now
to test the hypothesis that high pre- and postnatal HAP exposure negatively impacts neurocognitive
development. We will assess development in our DISCOVERY COHORT and an added VALIDATION COHORT of
newborns from a new group of pregnant (3rd trimester) women. We will monitor personal HAP exposures of
mothers and children, assessing biomarkers of inflammation and oxidative stress and blood levels of
micronutrients and heavy metals. We aim to assess neurocognitive development from infancy to age 8 years
as associated with: (1) prenatal and early childhood HAP exposures; (2) maternal psychosocial stress level,
maternal and child nutritional status, and child's home environment. Impact: Results will illuminate how HAP
exposures and maternal stress affect child neurocognitive development, informing policies to reduce HAP
through programs that promote use of clean-fuel cookstoves. We will develop language/culturally-adapted
assessments of child neurocognition—much needed in sub-Saharan Africa—and establish pilot performance
norms. This will build capacity for more research of this kind in Nigeria in the future.

Public health relevance
Narrative An estimated seven million yearly deaths are attributable to air pollution, with over 60% due to household air pollution (HAP) caused by use of biomass- or kerosene-fueled kitchen stoves in low- and middle-income countries. Women and children suffer the highest exposures, with documented ill effects on their respiratory, cardiovascular, and neurologic systems, along with mounting evidence of neurocognitive impairments in growing infants and children, due to HAP. The proposed work seeks to describe and quantify the risks of neurocognitive developmental impairment in relation to HAP with the goal of informing local and global public health policies and initiatives to reduce HAP.